Ion Channel Pharmacology for Pain and Epilepsy

Project Summary/ Abstract
The proposed work will integrate two long-standing lines of research in the laboratory. One is to
understand is to understand how the many types of ion channels present in a single neuron
work together to regulate its firing pattern. In earlier grant periods, we focused on the individual
gating behavior and functional roles of various kinds of calcium channels, sodium channels, and
potassium channels in different kinds of mammalian neurons. More recently, we have tried to
understand how the currents through the many kinds of channels in a given neuronal type
interact, often in surprising ways, to control the firing pattern of the neuron. In a second line of
research, we have characterized a variety of pharmacological agents that are targeted to
voltage-dependent channels. Much of this work originally focused on finding peptide toxins and
small molecules useful for separating components of current from specific channel types. Our
goal now is to use our expanding knowledge about the differences in ion channel make-up of
different kinds of neurons to rationally design novel compounds that can inhibit (or enhance)
activity of specific kinds of neurons. Hypothesizing that it is no accident that many clinically-
effective drugs act on multiple ion channels, we will attempt to design single compounds
deliberately designed to inhibit or enhance specific combinations of voltage-dependent sodium,
potassium, and calcium channels to differentially depress (or enhance) firing of specific neuronal
types of interest, including primary nociceptors, hippocampal and cortical pyramidal neurons,
various populations of cortical and hippocampal GABAergic neurons, and spinal cord motor
neurons, in ways designed to have clinically beneficial effects. A key element of our approach is
realizing that almost all small-molecule compounds targeted to voltage-dependent channels
interact differentially with different gating states of the channels, resulting in complex
dependence on voltage waveforms. Thus, differential inhibition of different neuronal types can
be based on their different resting potentials, action potential shapes, and firing patterns as well
as presence or absence of particular channel types being targeted. Our previous experience
with a range of cell types, channel types, and channel-targeted drugs will provide a strong
foundation for this effort.

Public health relevance
Project Narrative Understanding the basic mechanisms that control the excitability of central neurons will help in understanding the normal function of the nervous system as well as pathophysiology resulting in pain, epilepsy, ataxia, and other disorders. The work will specifically explore novel ways to differentially inhibit neuronal activity associated with pain and epilepsy while preserving other neuronal functions, by finding agents that inhibit or enhance specific ion channels with differential expression in different kinds of neurons.